Problems with Sustained Motor Performance in Parkinson's Disease and Effect of Neurofeedback: A Functional MRI Investigation

7. Project Summary/Abstract
Parkinson’s disease (PD) affects over six million individuals globally. With increasing life expectancy, this
number is estimated to double by 2040. The impaired ability to sustain a steady motor performance is a major
cause of morbidity in patients with PD. This is characterized by a rapid progressive decrement in the speed,
amplitude, or force of movements during continuous tasks (e.g., walking, writing). The standard
pharmacological and surgical therapies are ineffective in improving the decrement. There is a need for novel
targeted therapies with minimal adverse effects for better symptom control. The goal of the proposed mentored
research project is to assess the effects of functional magnetic resonance imaging (fMRI)-based
neurofeedback intervention on brain plasticity and sustained motor performance in patients with PD. FMRI-
based neurofeedback is a noninvasive intervention that improves individuals’ abilities to control their brain
activity in real-time. With practice, individuals can also learn how to self-regulate behavior that is associated
with this brain activity. This intervention has been used successfully in several neuropsychiatric disorders (e.g.,
anxiety, addiction), but reports of its use in PD are scant. Using fMRI-based neurofeedback combined with
motor imagery, we will train patients with PD to increase the functional connectivity strength between their right
insula and dorsomedial frontal cortex. These brain regions are important in initiating and sustaining voluntary
movement and are affected by the pathological process in PD. We will examine the effects of this training on
resting-state functional connectivity of brain networks and on motor performance. This proposal is in line with
the NINDS mission to seek fundamental knowledge about the brain and nervous system and to use that
knowledge to reduce the burden of neurological disease. If successful, this neurofeedback-guided motor
imagery training could be incorporated into rehabilitation programs in PD. Candidate: Dr. Tinaz is a movement
disorders neurologist. Her career goal is to develop a research program to study the neural basis of movement
disorders, specifically PD, identify targets for novel therapies, and investigate the brain changes in response to
interventions using neuroimaging. Dr. Tinaz seeks additional training in advanced fMRI methodology including
neurofeedback, behavioral intervention development, biostatistics, and in design and conduct of clinical trials
via didactic courses and hands-on learning. The project and career development plan will prepare her to
design large-scale clinical trials to assess the efficacy of neurofeedback intervention in PD. Environment: The
research and training activities will take place at Yale School of Medicine. The Magnetic Resonance Research
Center at Yale is a state-of-the-art facility providing the infrastructure and interdisciplinary expertise for
neuroimaging research. Dr. Tinaz’s mentors and consultants are experts on fMRI and clinical trial
methodology. Upon completion of the proposed project, Dr. Tinaz will be well poised to become an
independent clinician-scientist combining her expertise in movement disorders neurology and neuroimaging.

Public health relevance
8. Project Narrative Parkinson’s disease affects over six million individuals globally and causes significant disability leading to numerous hospital and nursing home admissions. Difficulty sustaining a steady movement speed and vigor greatly impairs motor functioning in everyday life of individuals with Parkinson’s disease, and current therapies fall short of alleviating this problem. Using neuroimaging techniques, the proposed research aims at examining the potential of neurofeedback training as a novel therapeutic intervention to improve motor functioning in individuals with Parkinson’s disease.